Administrative Support

Project Summary/Abstract
The Administrative Core will provide administrative, programmatic and fiscal management for the projects and
cores of the Program Project.
The goals are to organize staff and administer the projects and cores in conjunction with project leaders, core
directors and institutional staff; organize and conduct monthly meetings of Program Project participants as well
as annual meetings of Program Project participants. In addition, the aims will be to prepare the necessary
documents related to Program Project activities, including reports of the Program Project investigator
meetings, progress reports for official agencies and facilitate interaction between individual projects and
between projects and cores. The Core Director will monitor the progress of the individual projects on a regular
basis to maintain appropriate fiscal oversight of the projects and cores. The Core Director will oversee the
preparation of the necessary fiscal reports of official agencies and assure compliance with appropriate
regulations regarding experimentation with human subjects including gender and minor participation.